Development of Ingestible Biosensors to Enhance PrEP Adherence in Substance Users

ABSTRACT
The HIV epidemic continues to disproportionately affect individuals with health disparities. Marginalization,
substance use disorder, stigma and other health disparities contribute to decreased mood which influences key
health behaviors like adherence to oral HIV pre-exposure chemoprophylaxis (PrEP). These key disparities
contributed to the world failing to achieve the UNAIDS 90-90-90 goals in 2020 to end the HIV epidemic. One of
the pillars to ending the epidemic is improving uptake and persistent to PrEP. While efficacious, men who have
sex with men (MSM) with substance use disorders (SUD) experience multiple intersectional marginalized
identities which lead to PrEP nonadherence. Technologies to detect PrEP adherence patterns continue to be
developed to advance interventions that support adherence. The parent award, K23DA044874, develops a
preventive intervention, PrEPSteps, that leverages an ingestible radiofrequency transmitter (digital pill system)
to directly measure adherence. This digital pill then drives personalized adherence skills training that
addresses PrEP nonadherence at the moment it occurs. In this administrative supplement, we will integrate
measures of health disparities including the intersectional discrimination index and profile of mood states into
the fabric of the parent pilot randomized controlled trial to understand mechanisms of how these health
disparities influence uptake of the digital pill intervention and PrEP adherence. We will additionally conduct
formative qualitative interviews among parent study participants and healthcare providers who prescribed PrEP
grounded in the Consolidated Framework for Implementation Research (CFIR) to understand how health
systems may implement digital pills to measure PrEP adherence with a lens of health disparities.

Public health relevance
NARRATIVE Digital pill systems (DPS) provide an innovative method to measure adherence to oral HIV chemoprophylaxis (PrEP), yet uptake and engagement with the DPS may be impacted by different health disparities and marginalized identities. This administrative supplement integrates empiric evaluation of marginalized identities, intersectional stigma and mood into the parent award randomized controlled trial evaluating the feasibility, acceptability and potential for an effect of a DPS-linked adherence intervention among men who have sex with men with substance use disorder. The supplement additionally explores implementation factors associated with clinical use of the DPS to measure PrEP adherence through a health disparity lens.